High-throughput interrogation of long-range enhancers

Project Summary/Abstract
A majority of heritable disease-causing variation resides in the non-coding portions of the
genome. The leading hypothesis is that these variants perturb the function of cis-regulatory
elements, such as enhancers. A remarkable property of enhancers is that they often reside at
long distances from their targets. Thus, any framework for interpreting genetic variation must
account for the long-range functions of enhancers. There have been many genome-wide studies
of enhancers, yet we still lack an understanding of the sequence features that allow enhancers to
function over long distances. This lack of understanding is due to the absence of systematic
training data that measures the activities of enhancers as they are moved further and further from
their target promoters. We propose to address this gap by systematically measuring the activities
of enhancers at multiple fixed distances from target promoters. To collect this data, we will
introduce a high-throughput, genome-integrated reporter gene system that measures the
activities of enhancers at long distances from their target promoters. We propose to quantify
the effects of variables that contribute to long-range enhancer function. These variables include
the intrinsic strength of an enhancer, the number and arrangement of transcription factor binding
sites in an enhancer, and the chromatin environment in which an enhancer resides. A unique
strength of our system is that we directly compare the same enhancer sequences at long- and
short-ranges, which allows us to identify features required specifically at long distances.

Public health relevance
Project Narrative Enhancers control when and where genes are expressed. In the genome, some enhancers reside far from the genes they control. We aim to identify the properties of enhancers that allow them to control their targets over long-distances.